Nuclear receptor regulation of epigenetic mechanisms regulating HIV CNS latency

Background. This proposal entitled “"Nuclear receptor regulation of epigenetic mechanisms regulating HIV CNS
latency" is submitted in response to RFA-MH-22-280: Epigenetic Mechanisms Regulating HIV CNS Latency and
Neuropathogenesis Using Novel Single Cell Technologies”. Microglial cells are the main target of HIV infection
in the central nervous system (CNS) and form a reservoir of infection that persists despite antiviral treatment and
contributes to HIV-associated neurocognitive disorder (HAND).
Our goal. Using microglia cellular models, we demonstrated previously that the Nurr1 nuclear receptor, working
in conjunction with ligand-activated nuclear receptors, plays a critical role in the regulation of HIV latency. We
confirmed these observations in iPSC-derived human microglia (iMG), which provide the most informative
primary cell model to study the interaction between HIV and this important target cell. Here, we will test the
hypothesis that agonists of the Nurr1, RXR and RAR nuclear receptors lead to HIV silencing, suggesting
a novel therapeutic strategy for HIV infections in the CNS. Underpinning this work are two key technical
advances allowing the study of HIV in human microglia. First, we now have the capability to study HIV latency
using iMG alone or in combination with iPSC-derived neurons and astrocytes - the first available model systems
that do not rely on transformed cell lines. Second, in collaboration with the Cannon laboratory, we established a
humanized mouse model of HIV latency in microglia based on the new NOG-hIL34 transgenic mouse, which is
We demonstrated that the
humanized mice support latent HIV infection of human microglia. We have been able to identify latently infected
cells recovered from the humanized mice. In addition, we applied single cell RNA sequencing (scRNA-Seq) to
confirm that the microglia have transcriptional characteristics that match reference human microglia and further
identified subsets of reactive microglial cells that are associated with active HIV infections.
the only humanized mouse model to support full human microglial cell maturation.
Using these models,
we will apply highly sensitive chromatin immunoprecipitation (ChIP) and single cell sequencing and epigenomics
analyses to define nuclear receptor interactions with the HIV promoter region, and the mechanism of epigenetic
silencing on the HIV LTR.
How will we advance the field? Numerous clinically-effective, brain-penetrant drugs that regulate the nuclear
receptors are available, many of which are now FDA approved, and will be evaluated using the iPSC derived
cell models and in the humanized mouse model for their impact on HIV expression and latency in the context of
an intact brain. We are undertaking these technically challenging studies because it is only by working within the
context of authentic human microglial cells and an environment that better reflects the HIV-infected CNS, that
the underlying physiology is accurately represented. We believe these studies will allow us to obtain a convincing
proof-of-concept for this important therapeutic strategy to target HIV CNS Latency and Neuropathogenesis.

Public health relevance
Project Narrative In the United States, nearly half of all HIV infected individuals show neurocognitive defects despite effective anti- retroviral treatment suggesting potential widespread HIV infections that impact the CNS. We will test whether silent HIV infections in the brain become reactivated in response to inflammation and how they are regulated by a specific class of nuclear receptors using model systems derived from induced pluripotent stem cells and humanized mice. The availability of numerous clinically-effective brain-penetrant drugs targeting key microglial cell nuclear receptors will allow us to identify drug candidates with high therapeutic potential.